Biennial Mid-Atlantic Microbial Pathogenesis Meeting (MAMPM)

ABSTRACT
The 12th Mid-Atlantic Microbial Pathogenesis Meeting (MAMPM) will be held February 5-7, 2023 at
Wintergreen Resort and Conference Center near Charlottesville, Virginia. The purpose of the biennial
MAMPM is to foster communication and collaboration among scientists engaged in microbial pathogenesis
research in the Mid-Atlantic Region (North Carolina, Virginia, Maryland, The District of Columbia, West
Virginia, and Delaware). Numerous NIH/NIAID-funded investigators studying the virulence mechanisms of
pathogens of importance to human health are located in this geographic region and have participated in
multiple MAMPMs. MAMPM attracts scientists both from within and outside the Mid-Atlantic region; the 11th
MAMPM in 2022 featured 194 attendees from Mid-Atlantic states and the District of Columbia as well as from 8
states outside the region. The meeting achieved near-maximum registration despite the pandemic.
One of MAMPM’s key goals is to provide students, postdoctoral fellows, and junior faculty with the
opportunity to present their work to a knowledgeable audience, focused in this discipline, in a collegial yet
scientifically rigorous environment. MAMPM is a formative experience for young scientists’ professional
development and remains one of the most appealing and positively evaluated aspects of this conference.
MAMPM 2023 will consist of four sessions over three days. Each session will feature an invited keynote
speaker and talks by graduate students, postdoctoral fellows, and a limited number of junior principal
investigators, selected from the submitted abstracts by the Scientific Program Committee. Drs. Sunny Shin (U
Penn), Carlos Orihuela (U Alabama Birmingham), Craig Altier (Cornell Univ.), and Patricia Champion (Univ
Notre Dame) have agreed to be the MAMPM 2021 Keynote Speakers. Two highly interactive poster sessions
will be held to allow the opportunity for all participants to present and discuss their work face-to-face. MAMPM
2023 will be publicized through advertisements in professional publications, social media posts, and direct
electronic mailings to relevant departments at academic institutions, government and private laboratories within
the region and to members of the local American Society for Microbiology branches.
MAMPM remains committed to ensuring a balanced representation of women, underrepresented
minorities, and persons of disability in the leadership, conference participants, and speakers, including keynote
speakers. The conference will also feature a moderated, diversity-focused event that is open to all conference
attendees; based on feedback from MAMPM 2022, the discussion will be driven by topics and questions,
solicited from attendees prior to the meeting, related to diversity and inclusivity in the microbial pathogenesis
field. In addition, the meeting will include “Dine with a Keynote” opportunities for trainees to discuss
professional development issues.

Public health relevance
PROJECT NARRATIVE The purpose of the twelfth biennial Mid-Atlantic Microbial Pathogenesis Meeting (MAMPM) in February 2023 is to foster communication and collaboration between scientists engaged in research focused on disease- causing microbes in this geographic region. The goal of the organizers is to assemble a high-quality scientific program to attract outstanding principal investigators along with their undergraduates, laboratory technicians, graduate students, post-doctoral fellows, and junior faculty. This meeting will provide an opportunity for junior scientists to present their work to a knowledgeable audience in a supportive and collegial environment.